Structural and functional basis of ultra potent CHKV neutralization by human mAbs

DESCRIPTION (provided by applicant): Chikungunya virus (CHKV) is a re-emerging mosquito-borne alphavirus that cycles directly between humans and mosquitoes and causes a debilitating febrile illness in humans on a global scale. Autochthonous transmission in the New World now has been described, with outbreaks in five countries in the Caribbean. The potential for epidemics in North and South America is high due to the ubiquitous distribution of one of its primary vectors, Aedes albopictus. Despite the possibility for infecting and causing disease in millions, specific treatments or vaccines for CHKV are not available. A primary goal of this project is to define the molecular, genetic, immunologic, and structural characteristics of ultra-potent (<1 ng/mL activity) neutralizing human mAbs with broad activity against all genotypes of CHKV. Additional goals include defining the mechanistic correlates of protection by these ultra-potent neutralizing mAbs. In these studies, we will elucidate how antiviral Abs with exceptional inhibitory activity exert their action in cell culture and in vivo. The approach will include high efficiency isolation of human monoclonal antibodies, coupled with innovative antibody gene repertoire studies based on nextgen sequencing. Several hypotheses will be tested, including the concept that ultra-potent neutralizing activity results from features of both the antibodies (extensive mutations due to persistent CHKV infection) and the antigen (binding to quaternary epitopes on multiple adjacent envelope proteins and blocking structural transitions critical for virus entry or release). Although our focus is to understand how and why ultra-potent human mAbs inhibit CHKV, the studies likely will be relevant to general principles of antibody neutralization of many different viruses. Beyond defining the molecular and structural basis of Ab neutralization of CHKV, these studies will generate a group of fully human mAbs that can prevent and treat CHKV infection and persistence in mice, which could be developed in the future as a possible combination immunotherapeutic for humans. Studies in this project, while targeted against CHKV, likely will inform future Ab-based and/or vaccine efforts against other alphaviruses that cause human disease. We have assembled a unique group of investigators, including a human Ab expert, a molecular virologist with experience in Ab-virus interactions, and two accomplished structural biologists with specific expertise in alphaviruses, including CHKV, to pursue these studies.

Public health relevance
PUBLIC HEALTH RELEVANCE: Chikungunya virus is a mosquito borne virus that causes acute febrile illness and chronic inflammatory joint disease that can be severely debilitating. The virus is spreading worldwide and likely will enter the North America shortly. This application proposes detailed basic studies of the human immune response to Chikungunya virus that may provide the foundation for the design of new vaccines and antibody treatments